2022 Angiotensin GRC/GRS

PROJECT SUMMARY
The renin angiotensin aldosterone system (RAAS) is a key regulator of cardiovascular (CV) function, fluid
electrolyte balance, and homeostasis, and it influences many systems including the renal, neuroendocrine, and
immune systems. Perturbations of the RAAS trigger a cascade of events, including generation of vasoactive
mediators, oxidative stress, inflammatory responses, and tissue remodeling, thus contributing to end-organ
pathology and disease. In the 2022 GRC on Ang, we will discuss the most recent, cutting-edge discoveries in
the field and share insights on emerging new areas beyond the CV system such as the role of the RAAS in
adipose biology, bone marrow regulation, liver function, neurocognition, and immune responses. The
conference will focus on the latest advances of the RAAS from discovery science to clinical impact. A highlight
in 2022 will be the celebration of 22 years of the discovery of ACE2. ACE2 is a multifunctional protein, that not
only is CV protective by generating Ang-(1-7) and Ang-(1-9) from Ang II and Ang I respectively, but it is also,
tissue injurious by acting as the receptor for the SARS-CoV-2, the etiologic agent of the current worldwide
COVID-19 pandemic. The enigmas of ACE2 as a key enzyme in the protective arm of the RAAS will be a
highlight. The role of ACE2 as a major mediator and potential therapeutic target in COVID-19 will be debated
along with the controversies on the progression of COVID-19 infection and long-term outcomes in populations
treated with ACE inhibitors and/or angiotensin receptor blockers. The 2022 GRC on Ang will further feature
novel topics including sex-differences in the regulation and changes of the RAAS during the life course (fetal
programming, kidney development, and aging) will be further addressed. In line with precision medicine being
the next frontier in clinical medicine, the meeting will also highlight new advances in the pharmacogenomics,
proteomics, and metabolomics of the RAAS in human diseases. Preceding the GRC, we will have the 2022
Gordon Research Seminar (GRS), a special forum for graduate students, postdoctoral fellows, early career
researchers and other junior scientists to present and exchange new data and cutting-edge ideas. The 2022
GRS will focus on recent advances in RAAS studies beyond the classical paradigms, including new functions
of receptors from this system and providing trainees with an enhanced understanding of current tools to aid
their research, and cover a wide range of topics including the immune system, sex differences and aging.
Additionally, the mentorship sessions will address the interplay between academia and industry and discuss
approaches to translate scientific discoveries to the clinic and how to optimize impact. The aims are aligned
with the NHLBI, NIDDK and NIAID missions and initiative and the scientific themes that will be covered are of
direct relevance to these institutes. NIH funds requested will help attract young investigators and trainees,
including from underrepresented groups with limited opportunities to joint top national and international experts
in the RAAS for networking among researchers, clinicians, young investigators and trainees.

Public health relevance
PROJECT NARRATIVE The 2022 Angiotensin Gordon Research Conference (GRC) and Seminar (GRS) will focus on the latest advances in the renin-angiotensin-aldosterone system (RAAS), including ACE2 from discovery to clinical impact as a multifunctional cardiovascular protective protein and as a receptor for SARS-CoV-2, the cause of COVID-19. We will further discuss novel technical and therapeutic advances on the RAAS to improve understanding and management of cardiovascular and renal diseases and other pathologies and provide the means to foster a comprehensive mentoring and integrated network among trainees, including women, under- represented minorities, undergraduate and graduate students, postdoctoral fellows and early career scientists and expert investigators in the RAAS field, all of high programmatic relevance to NHLBI, NIDDK, and NIAID.